Admin Core

Administrative Core Abstract
The Administrative Core for the STAND ALACRITY Center will serve several functions. Led by the Center
Directors, the Administrative Core will serve as the overarching hub for setting the agenda and providing
oversight on all Center activities. The Administrative Core will create a Steering Committee that will set scientific
priorities (with input from the Methods Core), provide oversight on projects, resources, personnel, timelines, and
general Center administration, oversee training on ethics and human subjects research, and work with the
Scientific Advisory Board to improve upon the Center’s operations. Subcommittees of the Steering Committee
will focus on (a) stakeholder engagement (and will include several key stakeholders); (b) soliciting, reviewing,
and awarding of pilot projects led by junior investigators, in line with planned priorities in the Methods Core to
advance STAND’s implementation; (c) training and mentoring early career scientists; (d) disseminating Center
findings and products; and (e) planning for sustainability of STAND. The Administrative Core will include
stakeholders who are key leaders in local community colleges, California Community Colleges Chancellor’s
Office, and the Department of Mental Health as full partners in decision-making, and consideration of facilitators
and barriers to implementation state-wide. Finally, the Administrative Core will communicate research findings
and clinical products to the lay public and research and clinical communities via a website and other innovative
methods of dissemination.